ANALYSIS OF MCH DATA FROM THE NATIONAL LONGITUDINAL YOUTH SURVEY

This project has as its primary objective to analyze and publish data based on a series of annual interviews of young women (aged 14 to 21 on January 1, 1979) regarding their pregnancy outcome and the first year of life of the child. This survey allows analysis of trends over time in the maternal and child health field of, for example, the use of obstetric technology (diagnostic ultrasound, amniocentesis, etc.), and patterns in breast-feeding. In addition, a wealth of other data have been collected on the youth cohort sample in relation to their employment on work history, military service, educational attainments, etc. The Biometry Branch has joined in the funding of the data collection effort together with the Demographic and Behavioral Sciences Branch, Center for Population Research, NICHD. The mechanism of support for the field study is through an Inter Agency Agreement with the Department of Labor.